Epigenetic mechanisms of regulation of histone lysine methyltransferases involved in leukemia

Chromatin conformation underlies accessibility of enzymes that participate in transcription, replication,
recombination, and repair. Many chromatin-regulatory mechanisms ensure that enzymes such as RNA
polymerase II gain access to and efficiently transcribe chromatin. One of the mechanisms of chromatin regulation
is based on the posttranslational modification of histones. Chemical groups are deposited, read and removed by
specific families of enzymes to regulate chromatin structure. These modifications rarely function in isolation, and
there is often crosstalk between them that results in a coordinated transcriptional output. One of the prime
examples of such crosstalk is seen in transcription elongation, in which histones H3 and H4 are acetylated, H2B
is ubiquitinated, and histone H3 is methylated at lysine 4 and 79 (H3K4 and H3K79). COMPASS/MLL and Dot1
are the enzymes that catalyze methylation of H3K4 and H3K79 respectively and are evolutionarily conserved.
They play essential roles in processes such as transcription elongation, cell cycle control, and DNA repair.
Homologs are found, among others, in yeast, and mammals. Deregulation of Dot1L and MLL1, has been found
in several cancers, especially in leukemias, and Dot1L and MLL1 inhibition has emerged as a promising
therapeutic strategy. Trypanosome Dot1 is involved in evasion of the human immune system contributing to
devastating diseases such as African sleeping sickness. Understanding the mechanisms underlying Dot1 and
COMPASS/MLL1 functions is critical to discovery of novel strategies to fight diseases associated with their
deregulation. This proposal centers on finding and characterizing novel mechanisms of Dot1 and
COMPASS/MLL1 regulation. We will use biochemical, biophysical and structural methods to study these histone
methyltransferases. We will validate our mechanistic hypotheses in cells and in vivo. Using this integrative
structural and functional approach and different model systems will allow us to determine evolutionarily
conserved and organism-specific biological functions and modes of regulation of Dot1 and COMPASS/MLL1
which can be applied to therapeutic strategies for a variety of diseases.

Public health relevance
Dot1 and COMPASS/MLL1 histone lysine methyltransferases play essential roles in gene regulation and are deregulated in leukemias. In this application, we propose to use structural and functional approaches to elucidate the intricate mechanisms that underlie Dot1 and COMPASS/MLL1 regulation. These novel mechanistic insights will open new avenues towards therapies based on the epigenetic regulation of Dot1 and COMPASS/MLL1 activity.